INTRACELLULAR HOMOCYSTEINE &METHIONINE KINETICS IN HUMANS

Homocysteine has been established as an independent risk factor in cardiovascular disease, but the reason why some individuals have elevated plasma homocysteine concentrations is not thoroughly understood. Homocysteine is a sulfur containing amino acid that is a metabolic intermediate between the other sulfur containing amino acids,methionine and cysteine. Storch et al. developed a method using stable isotope tracers to evaluate sulfur amino acid kinetics.